Training in Translational ADRD Neuroscience (TITAN)

Project Summary/Abstract
Population aging is leading to a public health crisis in the growing number of people affected by Alzheimer’s
disease (AD) and Related Dementias (ADRD). It has been more than 15 years since the last FDA approval for
a new treatment for ADRD. To continue the dramatic progress over the last decade in understanding ADRD
pathophysiology we will require significant preclinical and clinical translational research to bring candidate
therapies to clinical use and grow a therapeutic armamentarium sufficient to curb the public health impact of
ADRD. Essential to this success will be a new generation of ADRD scientists, especially scientists with the
unique training and skills necessary to design and perform translational research. This training is rarely provided
through the traditional course of medical, clinical psychology, basic science, or biostatistical education. As a
result, there is a dearth of well-trained ADRD translational investigators. Moreover, there is inadequate diversity
among the current group of active ADRD translational investigators, limiting the unique perspectives and team
science synergies that could propel the field toward critical solutions.
We propose here a new training program in translational ADRD research titled “Training in Translational ADRD
Neuroscience (TITAN)” at the University of California, Irvine (UCI). This new training program will be broadly
inclusive of promising graduate students and junior translational scientists, such as medical doctors, clinical
psychologists, epidemiologists, biostatisticians, bioethicists, and neuroscientists. We have assembled an
outstanding and similarly diverse team of preceptors who will ensure the success of this new training program.
The program will develop novel training opportunities in ADRD translational research while also leveraging the
considerable scientific and training resources at UCI, including the NIA P30-funded Alzheimer’s Disease
Research Center (ADRC), which since April 2020 includes a Research Education Component with
complementary objectives. Similarly, the UCI Institute for Clinical and Translational Science (ICTS) is UCI’s
NCATS-funded CTSA program that offers synergistic training options to be leveraged, such as the K-club,
responsible conduct of research workshops, and KL2 funding mechanisms. We will recruit diverse trainees from
multidisciplinary specialties as well as individuals from nationally underrepresented racial and ethnic groups,
individuals with disabilities, individuals from disadvantaged backgrounds, and women.

Public health relevance
Project Narrative Alzheimer’s Disease and Related Dementias (ADRD) are global crises that require translational research solutions. A dearth of qualified investigators is available for the sustained effort that will likely be required to fully address this challenge. The Training in Translational ADRD Neuroscience, or TITAN, program will provide novel and necessary training to prepare investigators to lead the nation in research to reduce the impact of these deadly diseases.